Origins of Brain Somatic Mosaicism in Developmental Brain Disease

Abstract
Brain somatic mosaicism (BSM) refers to the accumulation of mutations within any of the billions of cells in
the human brain, which can occur from embryogenesis through adulthood. The extent, impact and
mechanisms of BSM on brain disease remain poorly understood. Prior work from the Brain Somatic
Mosaicism Network (BSMN), on which the PI served, made critical breakthroughs in reliability of mosaicism
detection, but also raised new questions, including the degree to which BSM exists in the healthy brain, and
the mechanisms by which BSM mutations explain disease.
Focal cortical dysplasia (FCD) is associated with substantial neuropsychiatric disability, and is the
most common cause of intractable epilepsy in childhood. Neuropsychiatric features are seen in 15-59% of
patients 5-7, and neuropathologically shows disrupted neurogenesis, migration, differentiation, and altered
neural excitability. We and others previously identified mosaic mutations in the mTOR pathway in a minority
of FCD cases, but most cases remain unsolved, and fundamental mechanisms are lacking.
We hypothesize that: 1] FCD mutations are similar to neutral somatic mutations in their patterns and
distributions, dictated by developmental processes, but differ in their functional effect. 2] BSM patterns, allelic
fractions (AFs) and allele sharing between cells can reconstruct cellular lineages and migratory histories. 3]
Study of FCD resected tissue can uncover novel causes of disease that would not be tolerated if present in
every cell. 4] BSM modeling in mouse can unravel disrupted signaling networks of complex mosaic mutations.
Our preliminary data shows: 1] From a post-mortem control cadaver, we validated 259 somatic
variants using 300X genome sequencing, and started to use these variants as ‘barcodes’ to reconstruct
lineage histories. 2] Deep sequencing from 314 FCD patient brain resections identified 12 new candidate
genes, highlighting signaling and synaptic dysfunction, and a novel ‘two-hit’ disease mechanisms. 3] We
established in utero mouse electroporation models to assess putative FCD variants as gain or loss of function,
and to assess effects of ‘single-hit’ and ‘two-hit’ mutations.
We propose three aims: 1] From control cadavers, we will reconstruct cell lineage across anatomical
domains using BSM as barcodes. 2] With this lineage information, we will study the origins of BSM
mutations in FCD, by recruiting new patients, performing both targeted and unbiased sequencing, and
identifying novel causes. 3] We will functionally validate putative deleterious alleles in animal models for
both ‘single-hit’ and ‘two-hit’ causes. The goal is to achieve a mechanistic understanding of the
extent of BSM in control individuals, to reconstruct neural lineages and to identify novel mechanisms in
developmental brain disease.

Public health relevance
Project narrative This proposal expands upon extensive preliminary data to achieve a comprehensive assessment of brain somatic mosaicism, in healthy and diseased brain. This genetic variation may play a role in normal development and may shape individual susceptibility and resilience to neuropsychiatric disorders. We will provide the first comprehensive estimate of the number and frequency of genomic variation in cells of the human brain and will test hypotheses about mechanisms responsible for their creation as well as their significance for brain development.